The UNC Core Center for Clinical Research: Admin Core

ABSTRACT – ADMINISTRATIVE CORE
The purpose of the Administrative Core is to provide leadership, oversight, coordination, and
general administrative support for all activities of the University of North Carolina (UNC) Core Center
for Clinical Research (CCCR). The Administrative Core’s specific goal is to maximize the scientific
integrity and dissemination of the CCCR’s work, which is focused on optimizing clinical research and
clinical trials that will advance clinical care and public health efforts targeted toward individuals with
Rheumatic and Musculoskeletal Diseases (RMDs) with a focus on osteoarthritis (OA).
This Core will facilitate the delivery of novel, innovative, and exciting services provided by our
Methodology and Phenotyping and Precision Medicine Resource Cores to our research community at UNC,
throughout the state of North Carolina (NC) and beyond. Our research community also includes members of
the Internal (IAB) and External (EAB) Advisory Boards, and specific collaborations with the NC Translational
and Clinical Sciences Institute (NC TraCS), home to our Clinical and Translational Science Award (CTSA).
This CCCR will build on the strong success of the current CCCR housed at the Thurston Arthritis Research
Center (TARC). The CCCR will leverage the Osteoarthritis Action Alliance (OAAA), a coalition of more than
150 organizations committed to elevating OA as a national health priority, and Communication Officers from
OAAA and TARC.
The Administrative Core’s purpose will be accomplished through the following specific aims: 1) Provide
leadership and vision to guide the CCCR in its focus on optimizing clinical research and clinical trials to
advance clinical care and public health efforts targeted toward all people with OA and other RMDs within the
mission of NIAMS; 2) Provide oversight and coordination for the Methodology and Resource Cores, ensuring
their success in meeting their goals; support enrichment programs for trainees including pilot and feasibility
grants; and evaluate metrics across all CCCR programs; 3) Continue to coordinate and integrate the services
of our valued and unique Stakeholder Advisory Board (SAB) across Cores and to maintain communication
links among the SAB, Executive Committee, Methodology Core, Resource Core, IAB, EAB, the CCCR
Research Community, and the other NIAMS funded CCCRs; 4) Provide structure and oversight of
communication and outreach efforts between the CCCR and the extensive ongoing TARC research activities,
OAAA, NC TraCS, and other UNC Schools, Departments, Centers, and Programs, as well as with public and
private organizations at the state, national, and international levels.